Training and Dissemination

Training and Dissemination Abstract
The field of Immunoengineering is an explosively growing combination of two diverse, complex
fields: engineering and immunology. In each, there is a widespread lack a fundamental
understanding of the other.
JH-TIE will take a leadership position in breaking down barriers between the fields. By providing
broad dissemination of immunoengineering principles, tools, and technical advances we hope to
greatly expand the emerging field of immunoengineering. The P41 mechanism is an ideal
opportunity to overcome the divide between researchers in immunology and engineering.
JH-TIE’s goal is to make the lexicon, approach, and tools of immunoengineering accessible to a
wide array of researchers. Our vision is to become a hub and thought leader for
immunoengineering. JH-TIE will host conferences and training programs in immunoengineering
to reinforce our mission. Our researchers will disseminate our work through scholarly
publications, workshops, conference posters and presentations, and a dedicated website for
use by collaborative participants worldwide.
With an integrated immunology-and-engineering approach, we can address a myriad of
challenges in a wide variety of applications such as cancer immunotherapy and tissue
engineering. Blurring the lines between immunology and engineering offers the opportunity for
unique synergy in medicine. Our education, training, and dissemination goals will help ensure
the impacts of JH-TIE not only extend well beyond our immediate research goals, but also
persist as our message and trainees propagate. The perspectives of both immunologists and
engineers will be integrated across education efforts ranging from the undergraduate to post-
doctoral levels and in platforms ranging from local seminars to an annual conference to virtual
learning modules.

Public health relevance
Training and Dissemination Narrative Not Applicable.